Investments, Life Events, and Health Within and Across Generations

PROJECT SUMMARY
A growing body of research documents that early-life environments play an important role in shaping child and
adult well-being. We now know that in-utero and early-life exposure to compromised health environments
(e.g., disease exposure, malnutrition) often produces adverse effects that persist well into adulthood. Many
government programs aim to counteract these negative effects by providing better access to nutrition, health
care, and early education. Recent studies find that childhood access to some of these programs (e.g., Food
Stamps, WIC, Head Start, Medicaid) lead to later-life improvements in individuals' health and economic
outcomes. Taken together, these two literatures—documenting the impacts of negative health “shocks” and the
impacts of positive investments—make clear that early-life influences have long-lasting effects. Yet, we know
surprisingly little about why the effects persist, nor do we know the scope for later-life investments to mitigate
the long-run effects of early-life trauma. We also do not know the extent to which later positive investments
sustain (or even amplify) the beneficial impacts of early social investments. Moreover, existing studies typically
focus on examining the impacts of specific health events or investments in isolation and ignore how additional
events or later investments might alter the trajectory of early-life experiences. A key aim of this project will be
to test how these programs interact with each other across the life course and into the next generation. We will
also investigate whether later-life interventions can reduce the persistent effects of early-life health shocks. To
achieve these goals, we will leverage policy variation across space and over time, including county-level
variation in the initial “rollout” of the Food Stamp and WIC programs, and state level differences in the 1980s
Medicaid expansions. We will link these program data to different sources of administrative and survey data,
which will provide us with very large samples that maximize statistical power, increase our ability to uncover
mediators, and detect the presence of interactive effects. The dataset describing how the policies rolled out and
associated caseloads and spending will be made available to all interested researchers. Together, these projects
will allow us to examine a wide range of intermediate- and long-term outcomes and will provide new
information on the efficacy of government policies intended to mitigate health and economic inequalities. For
example, understanding the extent to which public health investments mitigate the effects of health “insults” is
an important step towards identifying which government interventions can most effectively reduce long-run
health inequalities. Our work will also be critical for understanding the role of the safety net in combating
many early life challenges faced by disadvantaged children. Finally, our work will directly inform economic
models of human capital and technology of skill-formation.
1

Public health relevance
PROJECT NARRATIVE A growing literature documents important short and long run positive effects of many of the health, food assistance, and human capital interventions begun as part of the War on Poverty, yet we know little about how such programs interact with one another across the life-cycle nor do we know the channels through which these programs improve health. Our project will explore the extent to which exposure to different health, nutrition, and educational programs at different life stages can enhance the health and other impacts of these interventions and explore the channels through which these programs affect child, adolescent, and adult health and human capital as well as the health of the next generation. This will facilitate the development of successful interventions and programs to promote children and adult's health and well-being.